2023 NINDS Landis Mentorship Award - Administrative Supplement to NS121106 Control of Axon Initial Segment in Epilepsy

Over half of all people with temporal lobe epilepsy (TLE) are currently believed to suffer from inadequately
controlled seizures despite existing pharmacotherapies. One of the main obstacles to developing improved
epilepsy therapies is our insufficient understanding of the precise cellular and circuit mechanisms underlying
TLE. An important, but unresolved, question in TLE concerns the mechanisms underlying the excessive and
dysregulated production of action potentials at the axon initial segment (AIS) of excitatory principal cells (PCs).
Highly targeted synaptic control of the AIS is provided by a unique, evolutionarily conserved GABAergic cell type,
the axo-axonic cell (AAC). AACs are the only GABAergic neuron that forms synaptic contacts with the PC AIS,
placing AACs in a strategic position to regulate action potential transmission. However, due to technical
limitations, our knowledge of the exact connectivity of AACs and their in vivo function, along with their regulation
within the normal and epileptic hippocampus has remained extremely limited. Our R01 grant (NS121106)
focuses on leveraging a combination of recent technical breakthroughs to test the hypothesis that AAC-mediated
inhibition of PC discharges in hippocampal area CA1 is altered in chronic TLE in vivo, and that AAC optogenetic
modulation may exert effective seizure control and decrease cognitive comorbidities. While the prevailing dogma
has been that AACs exclusively innervate the PC AIS, our recent preliminary results surprisingly suggest that
AACs may also directly synapse on parvalbumin (PV) interneurons and thus regulate their activity. Additional
investigation into our finding would bring further nuance to our understanding of how AACs act as a central
controller of both excitatory and inhibitory network in CA1, and thus as key players responsible for TLE network
hyperexcitability. In this administrative supplement project, we propose to combine state-of-the-art in vivo
techniques to specifically probe the anatomical and functional connectivity of AACs with CA1 PV INs. In parallel,
we will perform similar approaches to study whether TLE mice show increased aberrant connectivity of AACs
onto PV INs or altered PV INs output activity in CA1. Together, the aims in our Landis award-related
administrative supplement will both benefit from and contribute to our R01 grant’s goal to define the function,
regulation and therapeutic potential of AACs in TLE, while also expanding opportunities to mentor trainees in
advanced approaches. Overall, this project will have a significant impact in advancing our understanding of key
circuit control mechanisms in chronic epilepsy and will aid in the future development of novel antiseizure
treatment strategies.

Public health relevance
Many patients with temporal lobe epilepsy experience repeated spontaneous seizures that cannot be controlled by existing medications. Epileptic circuit activity is characterized by excessive electrical signaling at a specialized part of neurons called the axon initial segment, which is specifically regulated by Axo-axonic cells, a unique but poorly understood regulatory interneuron. Our preliminary results surprisingly suggest that axo-axonic cells may not only control excitatory neuron activity, but also that of other inhibitory interneurons. In our Landis award- related administrative supplement project, we will take advantage of recent technical advances to determine the anatomical and functional connectivity of these interneurons with other inhibitory neurons, and how alteration of this connectivity in the epileptic brain could promote hyperexcitability.